2/2 Improving Mobility After Revascularization in Peripheral Artery Disease: The IMPACT PAD Trial

The IMPACT PAD Trial DCC Project Summary
This U24 application from the Wake Forest University School of Medicine (WFUSM) describes plans by expe-
rienced investigators and staff to serve as the data coordinating center (DCC) for the IMProving mobility After
revasCularizaTion in Peripheral Artery Disease: the IMPACT PAD Trial (IMPACT PAD), a 2 × 2 factorial N=386
trial. We will build on our successes in dozens of large, long-term trials and epidemiologic studies. Our DCC
experience will help ensure success in the implementation of this trial by overseeing all data related aspects of
the trial. We have a single specific aim: to provide project coordination, administration, data management,
and biostatistical support for the IMPACT PAD Trial. We will accomplish this by facilitating and guiding the
protocol development process, providing scientifically sound study design, excellent operational and analytical
methodology, a dedicated focus on recruitment, high quality follow-up and fidelity to the interventions, moni-
toring safety and working with the DSMB to ensure participant safety and careful study management, working
with the CCC to monitor the seven field centers, and by leading development and maintenance of the protocols,
manual of procedures (MOP), forms and other study documents. We believe that this trial will have nearly all
the complexities of large multi-center studies, particularly for the DCC in standardization across sites.
We have several strengths: (1) a team whose members are experts in the coordination of multi-center trials,
including several that are ongoing, (2) experience with peripheral artery disease (PAD) trials including the on-
going PROVE trial, (3) experience with exercise trials working with the intervention proposed in this trial and
nutraceuticals, (4) specific project management expertise, (5) a history of efficient and effective communication
with field centers, the executive committee, and the project office, and (6) success working with Dr. McDermott
(of the CCC) on three prior studies (LIFE, ENRGISE, and PROVE).
WFUSM views clinical trial conduct and coordination as a scientific undertaking, which advances through
continuous evaluation and innovation. While web-based randomized controlled trials (RCTs) have been con-
ducted for over two decades, we continue to develop new and innovative strategies for integrating web-based
technology into daily trial activities and incorporating other methods of electronic data capture into trial man-
agement. We coordinated ACCORD, which was the first large-scale RCT coordinated primarily over the web.
The ACCORD system has evolved into the Database for Efficient Administration of Clinical trial OperatioNs
(DEACON) system for web-based trial management which we use for all of our studies. We are constantly in-
venting and evaluating new features to add to the DEACON framework.
The highly experienced and talented team at WFUSM will create a state-of-the-art DCC for the IMPACT PAD
trial using proven coordinating center models. Personnel will be available from day 1 and have long-standing
working relationships across multiple NIH-funded studies.

Public health relevance
The PROVE Trial DCC Project Narrative Wake Forest University School of Medicine proposes to serve as the data coordinating center for a five seven (Northwestern, Dartmouth, Emory, U Chicago, U Pittsburgh, U Arizona, and U Southern California) 2 × 2 facto- rial randomized clinical trial (N=386) examining home-based walking exercise vs. attention control and nitrate- rich beetroot juice vs. placebo in people with successful lower extremity revascularization for disabling periph- eral artery disease. The primary outcome is 6-month change in the 6-minute walk. We would assume responsi- bility for developing a web-based data management system, for overseeing quality control including conducting site visits, for analyzing data, and preparing manuscripts.